Outcomes of children with juvenile idiopathic arthritis-associated uveitis

Project Summary Juvenile idiopathic arthritis-associated uveitis (JIA-U) is an inflammatory eye disease that affects 20% of children with JIA and can lead to cataracts, glaucoma, vision loss and blindness. Current screening guidelines are designed to identify children at risk for eye disease in JIA. However, pediatric rheumatologists' and ophthalmologists' ability to provide comprehensive screening for uveitis is limited because the guidelines have not been updated to include all juvenile arthritis subtypes and other known risk factors for vision-limiting complications of JIA. Screening in JIA and other related autoimmune diseases of childhood is crucial because early uveitis detection can prevent visual complications and influence therapeutic management. Likewise, institution of early aggressive therapy when needed may avert serious visual complications. To improve health outcomes and quality of life of children with JIA-U, we need a better understanding of risk factors for uveitis, long-term visual outcomes, and the effects of visual and physical disability on children's lives. Early and accurate identification of JIA-U through the identification of risk factors for susceptibility and severity of uveitis, standardization of outcome measures, and elucidation of the significance of HLA risk alleles would improve the evaluation of the impact of JIA-U and the understanding of disease etiology, pathogenesis and outcome. Likewise, an improved risk stratification scheme could reduce unnecessary ophthalmology visits and help us identify children at greater risk for severe eye disease and complications. The objectives of this study are to 1) Identify differences in the clinical characteristics and course of JIA-U in patients of European and African descent in children with JIA to identify clinical and genetic risk markers for uveitis, 2) Examine the risk factors identified over a 4-year prospective study of a cohort of children diagnosed with early JIA to determine which factors are associated with eventual development of uveitis, and provide data on their longitudinal profile, 3) Determine the impact of having both arthritis and uveitis on physical and visual disability, vision-specific QOL, and overall QOL using subjective and objective measures. Using a comprehensive biologic, genetic and psychosocial approach, we hope to develop more widely applicable risk stratification schemes based on JIA subtype, and to identify new risk factors that will identify the populations of children at greatest risk for severe disability and blindness so that interventions can be developed to improve their overall outcome. The candidate is a pediatric rheumatologist and an assistant professor of pediatrics at Emory University. She has obtained a Masters of Science in Clinical Investigation. She is devoted to a career in clinical outcomes research in children with autoimmune eye diseases. She has assembled an outstanding mentoring team with experience in pediatric rheumatology, pediatric ophthalmology, pediatric epidemiology, outcomes research and measurement, which are relevant to her objectives. This mentored award will help her become a successful independent clinician scientist.

Public health relevance
Project Narrative Juvenile idiopathic arthritis-associated uveitis (JIA-U) is an inflammatory eye disease that affects 20% of children with JIA. This research will validate known risk factors and identify new risk markers of JIA-U, identifying populations of children at greatest risk for severe disability and blindness. It is anticipated that early detection of JIA-U, regular monitoring for eye disease and complications, and institution of appropriate therapy can significantly improve our children's quality of life and long-term outcomes. __SpecificAimsTextDelimiter__ Specific Aims Juvenile idiopathic arthritis (JIA) is the most common rheumatic disease of childhood affecting over 300,000 in the United States; up to 20% of these children will develop JIA-associated uveitis (JIA-U). Uveitis, the most frequent extra-articular complication of JIA, can lead to severe vision-compromising complications including cataracts, glaucoma, and synechiae with a risk for vision loss and blindness1-3. Risk factors for JIA-U include JIA subtype, antinuclear antibody (ANA) seropositivity, early age of disease onset, and duration of disease. American Academy of Pediatrics (AAP) guidelines recommend that children with risk factors for JIA undergo regular ophthalmology evaluation to avert serious ocular complications since early disease is asymptomatic4. Risk factors that predict the clinical longitudinal course of JIA-U are not well characterized. This leaves an important gap in developing rational therapeutic guidelines that could better impact the physical as well as visual disabilities of these children. Early and accurate identification of JIA-U through the identification of risk factors for susceptibility and severity of uveitis, standardization of outcome measures, and elucidation of the significance of HLA risk alleles would improve the understanding of disease etiology, pathogenesis and outcome5. Likewise, an improved risk stratification scheme could reduce unnecessary ophthalmology visits, help us identify children at greater risk for severe eye disease and complications, and help to streamline limited healthcare resources. Improving quality of life (QOL) is a treatment goal for chronic diseases. However, outcomes and QOL studies in JIA focus on physical disability secondary to arthritis and largely overlook impairment from eye disease6. Visual outcome is measured by visual acuity (VA) and presence of protein flare or cells during the ophthalmologic exam only in the subset of patients who have routine screening visits or in those who are referred for symptoms of visual impairment. It is important to increase our understanding of the role that visual function plays in order to better assess patient centered outcomes and the global effects of visual impairment (psychological, physical, mental, social function) in children with JIA-U. To this end, we intend to show that incorporating measures of vision-specific QOL will improve measurement of outcomes that would complement ophthalmologic exams and global health measures and augment the assessment of the impact and utility of treatment5, 7, 8. The objective of this study is to characterize the epidemiology and clinical course of JIA-U in a mixed race cohort of children in an urban tertiary care center in the Southeast, and to identify differences in clinical and genetic risk factors that predict clinical course for severe ocular disease. Importantly, studies have shown an association between polymorphisms in HLA alleles and JIA-U wherein HLADR11 and HLA-B27 increase susceptibility to disease, and HLA-DR1 is protective9-14. However, HLA as a screening tool for disease risk and severity has not been evaluated in a cohort study. Using a comprehensive clinical, biologic, genetic and psychosocial approach, we hope to develop more widely applicable risk stratification schemes based on JIA subtype, and to identify new risk factors that will identify populations of children at greatest risk for severe disability and blindness so that interventions can be developed to improve their overall outcome and QOL. Aim 1. Identify differences in the clinical characteristics and course of JIA-U in patients of European and African descent. We will explore our database of 1000 children with JIA which consists of 18% African American children to identify clinical and genetic risk markers for uveitis through medical record review and questionnaire administration. a. Identify factors associated with susceptibility to and severity of JIA-U including labs (ANA, ESR), JIA subtype, ophthalmology exam, and HLA associations. b. Identify factors associated with need for aggressive therapy and develop an algorithm for treatment. c. Investigate HLA variants for association with JIA-U. d. Determine vision related, arthritis related and overall QOL after >7 years of disease. Aim 2. Examine the risk factors identified in aim 1 in a 4-year prospective cohort of children diagnosed with early JIA (duration less than 7 years disease) to determine which factors are associated with eventual development of uveitis to determine the 4-year longitudinal profile of children with JIA-U. Aim 3. Determine the impact of having both arthritis and uveitis on physical and visual disability, vision-specific QOL, and overall QOL using subjective and objective measures comparing children with JIA-U to JIA, and idiopathic uveitis.